Directed evolution towards bioengineering of fatty acid-activating natural product pathways

SUMMARY ABSTRACT
Natural products are potently active, privileged scaffolds that form the basis of our therapeutic arsenal across
all areas of human health. The continued development of natural products and their analogs will provide access
to compounds with improved activity and pharmacological properties while decreasing off-target effects. The
bioengineering of individual biosynthetic enzymes is one method of generating such novel secondary
metabolites. However, bioengineering efforts are often stymied due to a lack of fundamental understanding of
the discrete enzymatic transformations responsible for natural product biosynthesis. Likewise, whole pathway
metabolic engineering focused on generating novel secondary metabolites with targeted structural alterations
requires detailed knowledge of individual biosynthetic steps.
Fatty acyl-AMP ligases (FAALs) are pivotal biosynthetic domains that draw fatty acids from primary
metabolism for incorporation into more complex natural product scaffolds. The FAAL domains are often linked
with multidomain polyketide synthases either in cis or trans via structural linker regions or docking domains,
respectively. We hypothesize that these linker regions and docking domains are crucial to the transfer of fatty
acid chains of specific lengths to the downstream polyketide synthase domains and that we can modulate this
transfer by maintaining the appropriate key elements. This proposal seeks to identify the key residues that control
the activation and transfer of fatty acid chains in a model system for application to more complex pathways. As
well, we seek to develop a robust heterologous host capable of producing these fatty acid-containing metabolites.
In Aim I, we will use our model system olefin (Ols) synthase to identify and modulate the gate-keeping linker
regions and docking domains that govern fatty acid integration into secondary metabolites. Directed evolution
experiments using the bacterial two-hybrid system will allow us to dissect the key docking domains found in Ols
homologs that contain a trans enzymatic structure. In a complementary system, we will perform directed
evolution experiments targeted towards the linker regions of cis Ols synthases and directly assess metabolite
production via a temperature selection screening. Aim I will uncover the key structural elements in the model Ols
synthase for future bioengineering of more complex natural product enzymes with similar biosynthetic logic.
In Aim II, we propose to develop Pseudomonas putida for the heterologous expression of fatty acid-
containing natural products. The pathways for our model Ols synthase as well as the biosynthetic gene cluster
encoding for micacocidin production will be expressed in P. putida. The production and bioengineering of the
FAAL-ACP domains to integrate acyl chains of varying length will be encoded in this heterologous host to
facilitate engineering efforts. The bioengineering of the FAAL-ACP loading modules in Ols synthase and the
micacocidin pathway will be guided by our work from Aim I.

Public health relevance
PROJECT NARRATIVE We propose to identify and modulate key structural elements of biosynthetic enzymes that activate and transfer fatty acids for their incorporation into bioactive natural products. The directed evolution of the olefin synthase model system will allow us to dissect how these enzymes select and process specific fatty acid substrates for transfer to polyketide synthase domains. We will also develop a heterologous host for the expression of these fatty acid-activating biosynthetic pathways and the production of targeted bioactive natural products to facilitate metabolic engineering and bioengineering.